Understanding Mechanisms of Antibiotic Inhibition of Ribosomal Subunit Joining

Project Summary / Abstract
Antimicrobial resistance is rapidly on the rise due to the excessive use and over-prescription of antibiotics in
agriculture and medicine. Consequently, we are approaching a critical junction where bacterial infections may
no longer be treatable with conventional antibiotics. To tackle this challenge, it is crucial to gain a comprehensive
understanding of the mechanism of action of conventional antibiotics. This understanding will serve as a valuable
foundation for identifying strategies to rationally design novel antibiotics that emulate their mechanisms of action.
This research project focuses on the bacterial ribosome, the essential cellular machinery responsible for protein
synthesis, as an antibiotic target. Specifically, this research will investigate the process of ribosome formation,
which involves the assembly of large and small ribosomal subunits into a fully functional ribosome complex
through a process called subunit joining. This process is targeted by various antibiotics, including orthosomycins,
pactamycin, and tetracyclines. Currently, the biophysical parameters governing the molecular mechanism of
subunit joining and how antibiotics modulate these parameters to impede subunit joining remain largely
unknown. This research will characterize the kinetic, thermodynamic, and structural dynamics underlying the
molecular mechanism of subunit joining and elucidate how antibiotics impact these parameters. The project
comprises three specific aims, designed to actively engage undergraduate students and provide them with
opportunities to contribute to scientific presentations and publications. In Aim 1 the thermodynamic parameters
that govern subunit joining will be measured by conducting pre-steady state stopped-flow kinetic experiments at
various temperatures. These experiments will provide valuable quantification of the transition states and
activation energies required for subunit joining. By introducing antibiotics during these experiments, how they
increase activation barriers, transforming subunit joining into a translation bottleneck can be assessed. In Aim 2
molecular simulations will be implemented to investigate the structural dynamics of the intersubunit interface and
characterize non-covalent interactions that stabilize the fully formed ribosome. This approach will provide critical
insights into the interactions that are crucial to subunit joining. Implementing this as a characterization pipeline
we can include antibiotics in molecular simulations to assess how they destabilize intersubunit bridges at an
atomic level. Lastly, in Aim 3 cryo-electron microscopy will be performed to determine the structures of
meclocycline and methacycline bound to ribosomes, complexes for which no structural data is available. The
obtained structures can subsequently be incorporated into the characterization pipeline described in Aims 1 and
2, enhancing our understandings of how antibiotics impede subunit joining. Overall, this research project aims
to provide significant insights into the molecular mechanism of ribosomal subunit joining. By comprehending how
antibiotics alter the biophysical parameters of subunit joining, we can inform the development of novel antibiotics
that can be rationally designed to specifically target subunit joining to inhibit translation.

Public health relevance
Project Narrative Antibiotics represent the next global pandemic level threat as antimicrobial resistance is on a rapid rise and new antibiotic development is minimal; therefore, it is critical that the international community develop a sizeable and effective arsenal against bacterial infections. Development of novel antibiotics requires an intimate understanding of how conventional antibiotics function to inhibit bacterial growth. In this pursuit, this research aims to enhance our comprehension of a crucial stage in bacterial proteins synthesis, namely subunit joining, and explore the mechanisms through which conventional antibiotics specifically target and inhibit this process.